Regulation of Mitochondrial Function by Orphan Protein Phosphatases

PROJECT SUMMARY/ABSTRACT
Mitochondria are centers of metabolism whose activities need to be calibrated to meet changing cellular needs.
General dysfunction of these organelles is implicated in many common human disorders, including metabolic
syndrome, type 2 diabetes, obesity, non-alcoholic fatty liver disease, heart failure, various cancers and
neurodegenerative diseases, and general metabolic inflexibility, most often through unclear means. Defining the
pathogenic mitochondrial alterations that contribute to these metabolic disorders and devising new therapeutic
strategies to rectify them represent principal challenges in mitochondrial medicine. A potential contributor to this
dysfunction is aberrant intra-mitochondrial protein phosphorylation—a process recognized as critical for pyruvate
dehydrogenase regulation for more than 50 years, but relatively unexplored otherwise. Recent efforts from our
laboratory and others have now revealed that mitochondrial proteins are replete with dynamic phosphorylation
that changes reproducibly between healthy and diseased states, and that phosphorylation can alter the activities
of proteins involved in core metabolic pathways. Furthermore, we have connected select protein
dephosphorylation events to the poorly characterized matrix protein phosphatase PPTC7 and discovered that
PPTC7 disruption in mice causes profound metabolic defects and neonatal death. Given these emerging
findings, the premise of this project is that reversible phosphorylation may be widely important in calibrating
mitochondrial metabolism, and that its mismanagement could contribute to the pathophysiology of mitochondria-
related disorders. Rigorous new efforts to reveal how phosphorylation affects mitochondrial protein function and
to define the phosphatases that target each site may ultimately enable a new therapeutic strategy focused on
manipulation of the mitochondrial phosphorylation network. To this end, we have now extended our
phosphoproteomic analyses to 10 mitochondrial phosphatase knockdown lines using a CRISPRi system. This
rich dataset forges many unique connections between phosphatases and phosphoproteins and forms the
foundation for the further work proposed here. Based on these findings, we propose 1) to establish the functional
impact of phosphorylation on putative PPTC7 and HDHD5 substrates involved in core mitochondrial catabolic
pathways, including branched chain amino acid and fatty acid catabolism, and 2) to define the role of PGAM5 in
regulating mitochondrial cristae architecture by managing an extensive set of phosphorylation events on subunits
of the mitochondrial contact site and cristae organizing system (MICOS). Altogether, through a comprehensive
approach that combines mammalian physiology, omics-level analyses, and rigorous biochemistry, we aim to
make definitive connections between mitochondrial phosphatases and their substrates, establish a broad
framework for understanding the role of this post-translation modification in calibrating mitochondrial activities,
and ultimately pave the way for a new therapeutic strategy to rectify mitochondrial dysfunction.

Public health relevance
PROJECT NARRATIVE Mitochondrial dysfunction is implicated in a wide range of rare and common human diseases, yet the underlying features of this dysfunction are often poorly defined and extremely difficult to rectify. This proposal aims to elucidate the role of reversible phosphorylation in regulating select mitochondrial functions and to connect this phosphorylation to specific mitochondrial phosphatases. Completion of these goals will advance our basic understanding of mitochondrial metabolic regulation and define specific phosphatases as potential therapeutic targets for the treatment of mitochondrial dysfunction.